Research Capacity Core

SUMMARY
The Center for Research Resources (CRR) activity of the Ponce Health Sciences University (PHSU) Specialized
Center in Health Disparities is an essential and integral part of the research enterprise at our institution. CRR
fully supports the NIH Research Centers in Minority Institutions (RCMI) Center’s vision of further developing a
state-of-the-art biomedical infrastructure that enables PHSU investigators to become more competitive in
obtaining independent research grants from NIH and other funding agencies. CRR is led by experienced
scientists passionate about providing guidance and support to investigators and trainees. Technical staff will be
responsible for daily operations. By offering state-of-the-art resources to all researchers (e.g., faculty, trainees,
and staff), we will further the mission of NIHMD to develop and deliver healthcare discoveries to underserved
populations. CRR will continue to offer service, expertise, and training in advanced technology applications,
including Next-generation Sequencing, genomics, advanced data analysis, and other data-intensive research
areas, as well as the responsible conduct of research. CRR’s overarching goal is to provide a robust
infrastructure and research resources for investigators at PHSU, island-wide, and those from other RCMI
Centers to implement innovative research aimed at improving minority health and reducing health disparities.
The PHSU Specialized Center in Health Disparities is uniquely situated to put forward a centralized CRR capable
of accomplishing the following 3 specific aims. (1) Provide PHSU Specialized Center in Health Disparities
investigators with cutting-edge equipment, facilities, and technologies to enhance the quality and productivity of
clinical, basic biomedical, public health, behavioral, and clinical research projects. (2) Provide training and
support services to PHSU Specialized Center in Health Disparities investigators. (3) Foster the development of
additional competitive research projects and interdisciplinary collaborations to address minority health care
disparities by working with the Investigator Development and Community Engagement Cores. The services
provided by CRR will allow the acquisition of preliminary data for grant applications and subsequent publications
that will contribute to resolving health disparities. By combining expertise with the Community Engagement Core
and Investigator Development Core, as well as the leadership and advisors of RCMI, CRR will provide the triad
of customized services, education/training, and research development. Key areas include
Biostatistics/Bioinformatics, Basic, Clinical, and Behavioral Research on the causes and solutions for health
disparities. CRR will support the career development of researchers, particularly new and early-stage
investigators. CRR will impact the research community by supporting translational and community-level research
activities to reduce health disparities and improve health outcomes. Lastly, CRR will develop new tools and
technologies or repurpose existing tools and strategies to accelerate advances in the science of minority health
and health disparities.

Public health relevance
The Center for Research Resources (CRR) strengthens biomedical research capacity by providing investigators with access to advanced technologies, specialized expertise, and training necessary to conduct high-quality health-related research. By supporting the development of competitive research projects and facilitating data generation and analysis, the CRR enables studies that improve understanding of biological and clinical factors influencing health outcomes. These efforts improve the translation of research findings into scientific knowledge and strategies that inform healthcare practices and contribute to improved population health.